CK22-005 New England Center of Excellence in Vector-Borne Diseases

In New England, where the predominant vector-borne disease (VBD) burden is due to ticks, tick control and
suppression practices can barely keep up with regional endemicity conditions, despite the fact that New England
has a long history with ticks. With just 4.5% of the U.S. population, New England accounts for 20% of confirmed
Lyme disease cases in the U.S. This project proposes a New England Center of Excellence in Vector-Borne
Diseases (NEWVEC) to make significant progress in combatting ticks and other arthropod disease vectors in
the six New England states through applied research and technical evaluation of methods to prevent vector
bites, suppress disease-causing vectors, and promote public adoption of vector-control measures. To sustain
and amplify this public health imperative, NEWVEC will train students to enter the public health entomology
workforce to address VBD, and will engage stakeholders through a community of practice that can help its
research and training efforts remain relevant, effective, and impactful. The NEWVEC strategy has three
components: Applied research on tick suppression, Training of public health entomologists with expertise in
vector-borne diseases, and Community of Practice to enhance regional effectiveness of evidence-based
methods. Applied research projects will follow four parallel streams: 1) Standardizing and optimizing personal
protection and control products and applications for commercial and residential use; 2) Discovering and
evaluating emerging technologies to suppress ticks and prevent tick biting; 3) Designing and testing habitat and
host-targeted interventions for suppressing tick populations; and 4) Assessing human factors and public health
approaches for tick control. Work in these areas will be conducted by researchers at six New England
universities, supported by two core facilities: a Molecular Analysis lab for pathogen testing and taxonomic bar-
coding at the University of Massachusetts Amherst (UMA), and a Tick rearing and experimental test bed at the
University of Rhode Island. A multi-tiered training program in Public Health Entomology based at UMA will
develop concentrations and certificate programs at both the undergraduate and graduate levels to train highly
competent graduates for employment in the field, while providing a range of high-quality professional
development training experiences for public health professional staff and technical employees of commercial
applicator firms around New England. NEWVEC’s Community of Practice will promote extra-academic
collaboration in its research, promoting two-way transmission of vital knowledge among the center’s researchers,
its students and trainees, the public health stakeholder community, and others concerned with vector-borne
disease prevention in New England. NEWVEC will concentrate on the most important New England vectors,
most challenging barriers to VBD progress, and most promising and impactful vector control interventions and
methods. By being technically credible, NEWVEC will be relied upon by the VBD practice community, thus
influencing adoption of recommendations and promoting scalability to reach all areas in the New England region.

Public health relevance
Project Narrative The proposed project has great relevance to human health in that it seeks through applied research projects to advance progress across the six-state New England region in the prevention of bites, and suppression of populations, of ticks and other vectors that carry human disease agents. The research objective is to provide well-documented study findings regarding currently available technical approaches, emerging and novel technical approaches, methods involving host and/or habitat interventions, and approaches for heightening public acceptance and adherence, that public health practitioners and others can rely on in their work of combating vector-borne diseases in New England. The center’s other two objectives, training a new generation of medical entomologists and strengthening linkages and collaborative relationships with partners outside the academic community, are both of great relevance to human health in terms of growing the New England region’s human resource capacity to fight vector-borne diseases and growing a regional community of practice that includes state and local public health agencies.